A geroscience approach for treating Alzheimer's disease

Abstract
Geroscience is a multidisciplinary field that examines the relationship between biological aging and age-related
diseases through multiple processes. These processes are highly integrated with one another such that
targeting them as a group may be an effective approach to developing therapies to prevent or delay age-
related disease. Alzheimer's disease (AD) is an age-related disease and is expected to increase with the
number of elderly individuals rapidly rising in both developed and developing countries. Pharmacological
efforts to find disease-modifying treatments have met with limited success possibly because they have focused
on identifying a specific drug that targets a specific mechanism. AD is a complex disease involving numerous
mechanisms in line with processes of biological aging. Therefore, a geroscience approach to successfully
treating AD is a logical pharmacological concept. A cocktail of three repurpose drugs has been selected for
testing in this proposal based on established anti-aging effects in mice. Phenylbutyrate downregulates the
unfolded protein response and inhibits histone deacetylase thereby upregulating anti-inflammatory molecules.
Rapamycin inhibits mTOR, enhances vascular endothelial cell function and activates autophagy. Acarbose
acts as a caloric restriction mimetic to enhance mitochondrial efficiency and suppress oxidative stress. The
hypothesis is that a drug cocktail of rapamycin, acarbose, and phenylbutyrate, that targets multiple
aging processes associated with Alzheimer's disease will alleviate cognitive dysfunction and
neurological pathology in an aging AD mouse model. Aim 1 will determine if a slowdown in aging will slow
down the development of early stage AD dementia and neurological lesions using the 3-drug cocktail in 20-
month old AAV Aβ42/P301Ltau mice. The contribution of the cocktail will be evaluated in relation to
bioavailability, suppression of systemic disease, alleviation of cognitive impairment and other clinical and
pathological features, and lack of toxicity. Aim 2 will investigate aging processes that can increase the risk for
developing AD, focusing on inflammation, autophagy impairment, insulin/mitochondrial dysfunction and
oxidative stress, epigenetic dysfunction, and vascular impairment. Aim 3 will develop a molecular bridge for
Aims 1 and 2 studies as a unique metabolomics way of showing the relationship between phenotype and
processes of aging. Metabolomic profiles will be developed in brain and liver from Aim 1 cohorts. There will
also be an opportunity to assess effect of gender, age, and strain on metabolomics outcomes. The concept of
a geroscience drug cocktail that could successfully alleviate AD would be expected to have a significant impact
on the health of patients suffering from early symptoms of dementia and other AD related issues.

Public health relevance
Narrative. The goal of this geroscience project is to show that a cocktail of drugs targeting well accepted processes of aging will alleviate neuropathology and restore normal cognitive function in a mouse model of Alzheimer's disease (AD). The concept of a drug cocktail that could successfully treat AD would be expected to have a significant impact on the health of patients suffering from early symptoms of dementia and other AD related issues.